Identification of diagnostic biomarkers for flea-borne typhus

Abstract
Typhus group rickettsioses (TGRs) include epidemic typhus (ET) and murine typhus (MT), caused by Rickettsia
prowazekii and R. typhi, respectively. MT continues to cause serious infectious in otherwise healthy individuals
and results in increased health-care cost worldwide. ET is a bioterrorism and potential threat to public health in
situations with poor hygiene. Due to unspecific symptoms and lack of a reliable laboratory test at the early stage
of disease, diagnosis of TGRs has been problematic and accounts for the significant morbidity and disease
burden. Although often under-recognized, MT is the second most frequently reported rickettsial infection in the
US. Therefore, a novel antigen-based diagnostic assay for TGRs will be an important resource that will
ensure the Nation’s capability to recognize and treat these diseases. Our objectives in this research are
to identify the diagnostic biomarkers for TGRs and to develop a proof-of-concept immunoassay that can be
further advanced to an acute diagnostic assay for these infections. Our pilot studies have identified two rickettsial
proteins as the potential diagnostic targets by proteomic analysis using in vitro and in vivo experimental models
of MT. These two molecules have both shown a greater than 95% identity based on their amino acid sequences
in R. typhi compared to those in R. prowazekii. Thus, our central hypothesis is that immuno-detection of
diagnostic biomarkers will provide an antigen-based assay for early diagnosis of MT. We propose that this
diagnostic assay will also be applicable to ET. This project will test this hypothesis utilizing two linked and
complementary specific aims. Aim 1 will define the diagnostic biomarker(s) for TGRs. We will validate and
quantify two identified rickettsial proteins as potential biomarkers through proteomic analysis, as described in
our recently published studies. Aim 2 will develop an immunoassay for detecting the diagnostic target(s) for
TGRs. We will identify the potential diagnostic biomarkers in patients with confirmed MT during the acute phase
of infection using SID-PRM-MS assay. These diagnostic biomarkers will then be detected using a sensitive
chemiluminescent sandwich ELISA using a panel of specific monoclonal antibodies. The immunoassay's
application for diagnosing ET will be evaluated using R. prowazekii-infected guinea pig models. Completion of
these two aims is expected to yield a proof-of-concept immunoassay, which can be further developed into an
acute laboratory diagnostic assay for both MT and ET. This advancement will facilitate timely treatment,
favorable outcomes, and reduced healthcare expenditures.

Public health relevance
Project Narrative Typhus group rickettsioses (TGRs), including flea-borne typhus and epidemic typhus, continue to cause disease burden and result in significant health-care cost in the US, mainly due to lack of a reliable laboratory diagnostic test. The proposed project is to identify novel diagnostic target(s) for TGRs and to develop an immunoassay which will facilitate us not only making early diagnosis but also acquiring accurate epidemiological data for these diseases.